Astrocyte dysfunction in Spinocerebellar ataxia type 1 (SCA1)

ABSTRACT
The goal to effectively treat neurodegenerative disorders requires an understanding not only of neuronal
dysfunction, but also of dysfunction of non-neuronal cells that can initiate and contribute to neuronal pathology.
Spinocerebellar ataxia type 1 (SCA1) is a fatal, dominantly inherited neurodegenerative disease caused by the
abnormal expansion of CAG repeats in the Ataxin 1 (ATXN1) gene. SCA1 patients suffer from progressive
neuronal degeneration and reactive astrogliosis, especially in the cerebellum, leading to motor deficits. Despite
intense research focus on the disease mechanisms in cerebellar neurons, there are no effective therapies
available to cure, delay or ameliorate SCA1.
Astrocytes are brain cells that play fundamental roles in nearly all aspects of neuronal and brain
function. Recently, using single-nuclei RNA sequencing we demonstrated that cerebellar astrocytes express
Atxn1 at a level comparable to neurons (Borgenheimer et al., 2022). This raises a question of how mutant
ATXN1 in astrocytes impacts their function, contributes to neuronal pathology, and leads to SCA1-like disease
outcomes. To fill this knowledge gap, we aim to determine the molecular and cellular mechanisms though
which mATXN1 affects cerebellar astrocytes, and how astrocyte dysfunctions contribute to the behavioral and
pathological changes that are observed in SCA1 disease onset and progression.

Public health relevance
PUBLIC HEALTH RELEVANCE Spinocerebellar ataxia type 1 (SCA1) is a fatal, dominantly inherited neurodegenerative disease with no available therapies. We propose to determine the mechanisms through which mATXN1 induces dysfunction of cerebellar astrocytes and the precise impact of such dysfunction on disease outcomes to render deeper understanding of cerebellar physiology, SCA1 pathogenesis and possible targets for therapies.